Novel tracers for in vivo studies of waste transport by fluid flows in the brain

SUMMARY
Interstitial fluid motion in the form of convective flow is hypothesized to contribute to amyloid beta (Aβ) and waste
clearance by carrying extracellular proteins out of the brain. Failures of this system could contribute to
Alzheimer’s disease (AD), but are some aspects of this theory are still speculative. For examples, while the inflow
of fluid to the brain parenchyma is well documented, the outflow path is less clear. How exogenous tracers and
brain proteins get from the tissue into the lymphatics is still an open question. There are at least two ideas. The
glymphatic/lymphatic transport mechanism predicts that the inflow of fluid from the arteriole perivascular spaces
would be balanced by an outflow through the venular perivascular spaces. The Intermural Peri-Arterial Drainage
(IPAD) camp has identified that extracellular dyes and proteins aggregate near the basement membrane of the
arteriole vessels and hypothesizes that this compartment provides a conduit for waste clearance. The IPAD idea
predicts that waste exits along the arterioles, in the opposite direction of the glymphatic prediction, although both
are thought to feed into the lymphatics. There are experimental challenges in studying this transport because
fluid motion is usually tracked by injection of exogenous indicators that alter pressure balances and can only be
used for acute measurements. To overcome these barriers, new genetically engineered secreted tracers
(GESTs) which mimic endogenous protein production and are not complicated by artifacts from injection have
been prototyped. Microinjected adeno-associated virus (AAV) vectors drive the expression of GESTs in neurons
within a small volume of brain. The distribution of the secreted fluorescent protein using fluorescence imaging in
both tissue sections and intravital imaging can be used to map the transport. Because this tracer is produced by
neurons long after the injection of the viral vectors, pressures and fluid flow in the brain are not disturbed. In
addition, proteins such as Aβ are also secreted by neurons, so that the GEST distribution will replicate native
protein transport rather than the motion of exogenously injected tracers. While this strategy has shown promise,
new capabilities are needed to address the specific questions about fluid transport of waste proteins. First,
interstitial fluid flow rates in the brain require faster time resolution on the scale of minutes. A photoactivable
version of the GEST is proposed so that a volume of tracer can be “highlighted” and tracked as it moves through
the brain tissue. The direction and speed of motion could support or refute the different theories of flow-mediated
waste clearance. Second, it is not possible to detect GESTs in areas of faster flow or low concentration such as
the lymphatics. To detect the paths taken by secreted proteins, a new secreted, cell-permeant Cre is developed.
This will be used in floxed-stopped reporter animals to turn on reporter genes in cells that encounter fluids
carrying the Cre. Because the gene activation is permanent, this provides a cumulative assay of exposure to
Cre with good sensitivity to low concentrations. Finally, these new assays will be used to investigate whether
transport is altered in AD mouse models.

Public health relevance
NARRATIVE Fluid flow in the brain may contribute to preventing or delaying Alzheimer’s disease by reducing the amount of amyloid beta trapped in the tissue. This proposal develops tracers that can be used to track the fluid motion and to study how amyloid beta may be transported out of the brain.